CORE--ADMINISTRATIVE AND TECHNICAL

We are requesting support for a Core Unit to integrate the administrative and scientific activities of the Program Project, thus relating directly to the communal needs of the four individual projects. These needs include program administration, centralized technical facilities (tissue culture, biochemistry, and molecular genetic laboratories), service contracts for common equipment, supplies (e.g liquid nitrogen), travel to national meetings, and external consultation.